Education & Outreach Unit

The DFCI PSOC is committed to disseminate current and newly generated knowledge of the evolution, diagnosis and treatment of cancer as well as physical sciences approaches to cancer research. This is the basis for our educational outreach and training initiatives designed to enhance the Center and integrate divergent fields. Scientific experts and seasoned mentors will offer a rich program intended to enhance the interaction and training of physicians and scientists both regionally and at off-site facilities from regularly scheduled seminars to specific working groups. We have designed targeted programs and individualized mentorship for faculty, postdocs, graduate and undergraduate students with an evaluation and enhancement process. Our PSOC Administrator has a dual role as the Educational and Outreach Director and is committed to reassessing the effectiveness of all educational programs offered. The Administrator and PIs will meet on a weekly basis to ensure that goals are being met. As part of our education and training program, we will offer an extensive postdoctoral training program, a graduate course at Harvard University on “Mathematical Modeling of Cancer”, participation in the Harvard Stem Cell Institute summer internship program, a Junior Investigator Symposium, a seminar series, an annual meeting, two small retreats yearly for our PSOC members, and additional research training opportunities relevant to the PSOC research community. In addition, we have created a comprehensive outreach program targeting diverse populations such as patients, high school students, and the general public. We will offer community lectures, a Research on the Road program, social media campaign, participation in DFCI outreach initiatives, patient lecture series, and host a Women of Science conference. The expected result of our initiatives is the enhancement of professional knowledge with the immediate goal of stimulating new research ideas and outcomes that integrate back into the PSOC framework.